Support of caBIG^ activities

This funding is in support of various caBIG[unreadable] activities including such as: caBIG TPM, IOB Quality Assurance, IOB Apps Engineering, IOB Core Engineering, CAGRID PORTAL, IOB CABIG VCDE, Community Alliance and Consultant-International Outreach